Cancer Center Support (Core) Grant

Overall: Summary/Abstract
Over the past four decades, MIT has had a focused effort in cancer research, first in the form of the MIT Center
for Cancer Research (CCR) and, since 2007, as the Koch Institute for Integrative Cancer Research at MIT.
This effort has been continuously supported by a Cancer Center Support Grant (CCSG) from the National
Cancer Institute (NCI), providing the designation as an NCI-designated Cancer Center at MIT. By supplying
infrastructural support for Core Facilities and other organizational components of the Koch Institute as well as
funds for faculty recruitment and pilot projects, this CCSG is a critical resource for cancer research at MIT.
From the establishment of the CCR in 1974 to the transition to the Koch Institute and continuing to the present,
the NCI Cancer Center designation has had a strong influence on the MIT administration, leading to significant
institutional support over this entire period. The investment in construction of the Koch Institute building
(opened in late 2010) is a recent indication of this support. The building brings together 27 cancer scientists
and cancer-oriented engineers to form a highly inter-disciplinary and collaborative research environment. The
building is also the hub of cancer research on the MIT campus, with a nearly equal number of Members of the
Center having their laboratories in other research buildings nearby. The 56 Center Members are drawn from
eight academic departments at the School of Science or School of Engineering at MIT. Beyond the discovery
research and technology development being pursued by the Members of this Center, significant emphasis is
placed on translational research in the form of collaborations with clinical centers and industry partners.
Research in the Koch Institute is organized into three Programs. Each of these Programs has made significant
advances over the current grant period. Program 1: Genetic & Cellular Programs in Cancer is co-led by Drs.
Phillip Sharp, J Christopher Love, and Eliezer Calo. Program 2: Cancer Biology & Immunology is co-led by
Drs. Richard Hynes, Dane Wittrup, and Stefani Spranger. Program 3: Systems and Engineering Approaches
to Cancer is co-led by Drs. Michael Yaffe, Scott Manalis, and Angela Koehler. These Programs function to
stimulate new research initiatives by their Members as well as to foster intra- and inter-programmatic
collaborations. In aggregate the 56 Members of this Center have published 1006 cancer-related articles over
the past grant period. Of those, nearly 18% have involved multiple Members. The Center has a cancer-related
funding base of $58,596,507 TDC (see Data Tables 2A/2B).

Public health relevance
Overall: Project Narrative The Koch Institute for Integrative Cancer Research at MIT is a highly inter-disciplinary Cancer Center that brings together the great strengths at MIT in cancer science and cancer-oriented engineering to address long standing problems in the diagnosis and treatment of cancer. The Koch Institute is focused on basic discovery and technology development; however, advancing projects toward the clinic and to the benefit of patients as rapidly as possible is a high priority. This occurs through extensive interactions with clinical centers as well as industry partners.